Toward vocal fold scar mitigation through CRISPR/Cas-9-mediated gene editing of fibroblasts

ABSTRACT
Vocal fold (VF) scarring negatively impacts both voice quality and quality of life, and effective treatments are
currently lacking. VF fibroblasts (VFF) play a crucial role in VF scarring, as they are involved in wound healing
and the production and remodeling of the VF lamina propria extracellular matrix in response to injury. Recent
advances in understanding VFF gene expression have identified a signaling pathway that may contribute to the
scar-like phenotype of differentiated VFF, specifically myofibroblasts. This research proposal aims to identify
gene targets that could prevent the differentiation of VFF into myofibroblasts, thereby reducing the
overproduction of fibrous proteins and excessive cell proliferation that contribute to scarring. The central
hypothesis of this proposal is that inhibiting TGF-β signaling pathways will reduce VFF differentiation and
proliferation, leading to a gene expression profile and cellular behavior more characteristic of undifferentiated
VFF, with a concomitant reduction in fibrosis. We plan to quantify the effects of gene editing in VFF using an in
vitro model and perform functional testing to address specific hypotheses. Specifically, we will target two
pathways within the TGF-β signaling cascade: SMAD-dependent pathway and PI3K/AKT SMAD-independent
pathway. CRISPR/Cas9 technology will be used to knock out specific genes involved in these pathways. After
gene editing, we will assess the cellular response using assays for proliferation, differentiation, and collagen
contraction, and perform bulk RNA sequencing to examine gene expression changes. This research is the first
to apply CRISPR/Cas9 technology to edit VFF, providing genetic control over VFF differentiation in the context
of scarring. The proposed study will shed light on the role of these specific genes and pathways in
myofibroblast function. Given that no reliable, minimally invasive treatments for VF scarring currently exist, this
proposal may reveal novel targets for further investigation and potential therapies for VF scar remediation.

Public health relevance
NARRATIVE Voice disorders affect nearly 30% of Americans at some point during their lifetime. Vocal fold scarring, a common cause of voice disorders, lacks a consistent and reliable treatment. In this research proposal, we seek to use specific vocal fold cells, called fibroblasts, to identify possible genetic targets to reduce vocal fold scarring using novel approaches - CRISPR/Cas9 gene editing and RNA sequencing.